EVALUATION OF CGP 19835A LIPID INFUSION FOR TREATING MALIGNANT MELANOMA

This study will attempt to evaluate the safety and tolerability of CGP 19835A lipid and its immunomodulatory effects on selected indicators of immune function. The anti-tumor activity of CGP 19835A lipid will also be assessed.